Spatial Transcriptomics Explorer (STE): An open-source resource for visualizing spatial gene expression data

Abstract
This application is being submitted in response to the Notice of Special Interest (NOSI)
identified as NOT-CA-23-045.
Spatial transcriptomics (ST) is transforming our understanding of gene expression patterns in
relation to tissue architecture. Various ST techniques such as 10x Genomics Visium and
Nanostring GeoMx DSP have advanced our knowledge, but the resulting data is large, complex,
and costly to generate. Collaborations and data sharing among researchers with respect to
these data can greatly benefit the scientific community. However, challenges like difficulties in
analyzing data from different platforms and the computational and administrative burden of
downloading large datasets currently hinder effective collaborations. To address these issues,
we propose the development of a prototype Spatial Transcriptomics Explorer (STE), a modular,
user-friendly application for visualizing ST data within various Division of Cancer Biology (DCB)
consortia. STE will offer a platform-agnostic, open-source visualization resource, compatible
with data from multiple platforms. Through the cohort builder, gene-based query, and spatial
query modules, the STE will help researchers quickly examine genes or regions in diseased and
normal tissues. Deployment of this resource widely in the DCB consortia will provide a valuable
tool for researchers and clinicians with varying computational expertise, promoting inclusive
data sharing and accelerating discoveries in spatial transcriptomics.

Public health relevance
Project Narrative Spatial transcriptomics (ST) is revolutionizing our understanding of gene expression patterns in the context of the tissue microenvironment through generation of large, complex, and expensive multimodal imaging and transcriptomics data. To optimize resource usage and foster collaborations, we propose the development of a modular, user-friendly web-based application, the Spatial Transcriptomics Explorer (STE). This application will be deployable for a single research group or for a consortium or researchers to address the 1) challenges of analyzing ST data from different platforms side-by-side and 2) reduce the computational and administrative burden of downloading large datasets under access restrictions. In partnership with clinician-researchers, we aim to create a platform-agnostic, open-source visualization resource compatible with multiple ST platforms. Our respective expertise in ST data generation, analysis, and visualization platform development will ensure a scientifically insightful but easily generalizable product. We hope that the STE will facilitate collaborations within the Division of Cancer Biology consortia, stimulate hypothesis generation and testing, and make these complex data easily accessible to researchers and clinicians without extensive computational resources.